HORMONALLY CONTROLLED MODEL OF IMPLANTATION IN SPAYED RHESUS MONKEY

The goal of this project is to determine whether artificial menstrual cycles in ovariectomized monkeys could support implantation and pregnancy after transfer of cryopreserved, in vitro fertilization-produced embryos. Spayed, rhesus monkeys first received a 3 cm estradiol (E) implant (day 0). On days 9-13, increasing doses of E were injected to simulate the estradiol surge. To mimic P levels during the luteal phase, a 3 cm progesterone (P) implant was placed sc on day 14 followed by a second P implant on day 17; one P implant was removed on day 24, and the second on day 28 with induction of menses within 2 days. A second artificial cycle was administered, with embryo transfers performed on day 17. Embryo donors received either urinary or recombinant human follicle stimulating hormone q human luteinizing hormone to stimulate the growth of multiple follicles, followed by urinary or recombinant human chorionic gonadotropin (hCG) to induce ovulatory maturation. Mature oocytes were harvested 27 h post-hCG, and inseminated in vitro. Resultant embryos were cryopreserved, then thawed prior to transfer at the 2- to 4-cell stage (2-3 embryos/recipient). In Phase 1 of this study, 4 recipients underwent sequential oviductal followed by transcervical embryo transfer. Biochemical pregnancy, associated with increases in circulating bioactive macaque CG for up to 36 days of gestation, was noted in 1/4 recipients after oviductal and 1/4 after transcervical transfer of embryos derived from urinary gonadotropin treatment. Following 11 oviductal transfers (n=5-6 recipients) of embryos derived from recombinant human gonadotropin stimulation in Phase 2, one singleton pregnancy resulted in delivery of a normal stillborn female on day 132 of gestation. In Phase 3, oviductal transfer of recombinant human gonadotropin-derived embryos to 4 recipients yielded one singleton pregnancy that is currently ongoing. Thus, implantation and pregnancy can occur when IVF-produced, cryopreserved embryos are transferred during artificial menstrual cycles in spayed rhesus monkeys. Current efforts are aimed at improving implantation efficiency through further optimization of this animal model.